Interdisciplinary Research Training in Trauma and Violence (IRTTV)

The goal of this interdisciplinary research preparation is to train nursing, public health and medical
scholars in the science of risk factors, neurophysiological, developmental, physical and mental
health sequelae, and interventions across the translational research continuum for lifetime
experiences of trauma and violence. Pre and post doctoral fellows will be mentored in a unique
multidisciplinary mentoring team model using inter-professional education by experienced trauma
and violence researchers to conduct: 1) policy and practice relevant epidemiological and clinical
risk factor analysis and theory testing studies addressing trauma throughout the lifespan, and 2)
design and test primary, secondary and tertiary interventions to prevent, assess, and ameliorate
the psycho-neurophysiological, developmental and behavioral effects of trauma and occurrence
&/or reoccurrence of violence (experiencing and using). The scholars obtain interdisciplinary
content in: 1) risk factors (including social determinants of health) for and neurophysiological
(rapidly expanding related brain science), physical and mental health and developmental
outcomes of violence and trauma (experiencing and exposure to community, family, antenatal,
youth and collective violence, suicide, violence against childbearing women and children) 2)
social, ethnic and cultural influences on trauma and violence etiology and outcomes including
violence related health inequities and how health inequities in both policies related to violence
and access to care can result in more severe physical and mental health outcomes for ethnic
minority and other marginalized populations, 3) culturally tailored interventions and RCT
(pragmatic trials) and other strategy evaluations thereof (e.g. implementation science), 4) ethical
issues and social responsibility in the conduct of violence related research, and 5) multiple
methods approaches to violence related research, including using “big data” and combining
qualitative and quantitative data and/or physiological data. Our faculty is diverse in areas of
expertise, disciplines and race/ethnicity as well as having outstanding experience in research
training and research, policy and community organization collaborations. This application seeks
support for five predoctoral positions across 4 Public Health and two nursing departments and
2 postdoctoral positions across the 3 schools (Nursing, PH and Medicine) and addresses
multiple priority areas of NICHD.

Public health relevance
Violence and witnessing violence results in intertwined, complex mental and physical health trauma responses including from injury and mortality (homicide, suicide, maternal and neonatal mortality) to chronic physical and mental health conditions for adults and children. Risk factors for violence and trauma are also complex and include individual, family and community factors. Interdisciplinary training is necessary for nursing, public health and medical researchers to understand and design appropriate violence prevention and interventions to prevent future violence and subsequent traumatic health problems.